Phenotyping Corticospinal Axon Degeneration in Preclinical ALS Models.

Over 30,000 Americans currently suffer from amyotrophic lateral sclerosis (ALS) which is characterized
by progressive paralysis due to the degeneration of nerve cells in the brain and spinal cord that control
movement. Almost all cases of ALS are eventually fatal, and the rapid progression of the disease makes it
particularly devastating, with most deaths occurring 2-5 years from diagnosis. No cure exists for ALS and the
only available treatments slow disease progression by merely a few months Therefore, a great need exists for
more effective and specific therapies that can stop or even reverse neurodegeneration. Innovation for such
therapies will only arise from a better understanding of the molecular and cellular mechanisms underlying the
pathological process. Degeneration of the “upper” motor neurons (UMNs) in the cerebral cortex that project to
the spinal cord is an important hallmark of ALS and a cortical indication is required for diagnosis. The severity of
cortical pathology also correlates with disease progression and prognosis. Because UMNs are difficult to
distinguish from other cortical cell types they are often overlooked in preclinical studies. Therefore, properties
that make them vulnerable to disease-causing mutations and the mechanisms that underlie their degeneration
have remained a mystery.
The proposed study aims to overcome this by utilizing cutting edge molecular, cellular, and anatomical
techniques to interrogate neurodegenerative mechanisms in UMNs during disease progression. Specifically, this
project will focus on the local pathology of the axons of UMNs in the spinal cord. Loss of these fibers is an early
phenomenon of ALS and is characterized by a thinning and scarring of the corticospinal tract (CST) and may be
a triggering factor for disease onset. Abnormalities in CST axons have also been observed at early time points
in preclinical animal models, often preceding UMN loss. This grant will utilize a common mouse model of ALS
that utilizes disease-linked mutations in the SOD1 gene (SOD1G93A) and recapitulates the neurodegeneration
seen in human patients. In Aim 1, advanced viral tracing techniques will be used to label the neurons in the
mouse spinal cord that receive direct synaptic input from UMNs and map changes in connectivity during disease
progression. In parallel, the translating ribosome affinity purification (TRAP) method will be used in Aim 2 to
monitor changes in the genes that are locally expressed in the axons. Aim 3 will examine the bioenergetic
properties of the axons by employing a novel approach to isolate axonal mitochondria in order to perform
biochemical and metabolic analyses during disease progression. This exploratory study will be the first to directly
correlate changes in anatomy, gene expression, and bioenergetics specifically in degenerating axons, therefore
laying a foundation for future work investigating mechanisms of CST pathology.

Public health relevance
PROJECT NARRATIVE ALS is characterized by the degeneration of “lower” motor neurons in the spinal cord and “upper” motor neurons in the cerebral cortex, with atrophy and scarring of the corticospinal tract (CST) being a hallmark of disease pathology with degeneration of CST axons preceding cell death in preclinical models. The proposed research will utilize cutting edge molecular, cellular, and anatomical techniques to characterize changes in the corticospinal circuit, locally translated genes, and biochemical and bioenergetic properties of CST axons during disease progression in animal models of ALS. The results obtained from this work will provide a better understanding of the molecular and cellular mechanisms that underlie axonal degeneration and identify novel pathways for future research for exploring therapeutic strategies.